Machine Learning remedies to unmeasured confounding biases in environmental mixture studies

SUMMARY
To draw causal interpretation and policy recommendations from epidemiological investigations of
environmental mixtures, it is key to quantify the impact of residual unmeasured confounding. Rigorous
evaluation of this potential threat to causal inference faces several challenges. This application, in response to
PA-20-195, will accomplish the following goals: (1) develop sensitivity analyses approaches to detect and
assess the impact of unmeasured confounding bias in the estimation of the overall environmental mixture
effect, single pollutant main effect and interactions among mixture components accounting for uncertainty on
unmeasured confounding structure and strength; (2) apply these approaches in the analysis of a birth cohort of
Bangladeshi mother-infant pairs to characterize the joint effect of metal exposures on child development; (3)
develop and disseminate computationally efficient and user-friendly software for widespread application of the
methods in environmental epidemiology. The proposed work will address methodologic gaps in the causal
investigation of health effects. First, most of observational environmental mixture studies are plagued by
unmeasured confounding bias. Approaches for quantitative bias analysis to investigate the impact of this bias
either assume a single exposure or a single unmeasured confouder and are therefore inadequate. Second,
multicollinearity, skewness of exposures, complex exposure-response relationships and intermediate or time-
dependent confounding challenge valid estimation and inference. We propose to fill these methodological gaps
by developing and applying probabilistic sensitivity analyses and negative control exposures approaches for
quantifying the causal health effects of environmental mixtures under the counterfactual framework in the
presence of unmeasured confounding. We will develop and apply the new methods to estimate the mixture
effect and individual pollutant effect that incorporate quantitative bias analysis for multiple unmeasured
confounders and allow for complex exposure-response relationships of metals and dimension reduction
adopting the Bayesian multiple index model (Aim 1(a)). The approach will accommodate multiple potential
unmeasured confounding structures and incorporate uncertainty on unmeasured confounding structure and
strength (Aim 1(b)). We complement this approach with the negative control exposures approach, which allows
to detect unmeasured confounding leveraging alternative assumptions on the confounding structure (Aim 2).
We will investigate the effect of metal mixtures on birth length and child neurodevelopment in a Bangladeshi
cohort evaluating the impact of unmeasured confounding bias (Aim 3(a)). We will develop user-friendly and
efficient R packages that implement the proposed methods and R shiny apps to allow interactive visualizations
of the results under different hypothesized unmeasured confounding scenarios (Aim 3(b)). Our work has great
potential to have broad impact on environmental epidemiology research and beyond.

Public health relevance
PROJECT NARRATIVE This project responds to the research need of more rigorous evaluation of unmeasured confounding in epidemiological analyses of environmental mixtures. We will develop advanced models for causal inference based on Bayesian probabilistic sensitivity analyses and negative control exposures approaches along with computationally efficient and user-friendly R packages to evaluate the impact of unmeasured confounding when causal inferences on multiple continuous exposures are sought. The proposed approaches will enable causal inference on joint exposure effects to inform policy for environmental exposures and child development.